Mechanisms and indicators of inflammasome signaling in Parkinson’s disease

PROJECT SUMMARY
The ViCTER Consortium has been established to characterize mechanisms of inflammation in the peripheral
myeloid immune compartment, determine their impact on pesticide-driven neurodegeneration, and see if plasma-
borne indicators of these processes are associated with military occupation and Parkinson’s disease (PD). It is
widely accepted that complex gene-environment interactions underlie the risk of PD. Our work in pesticide-
exposed mice and PD patients indicates that environmental toxicants converge on the NLRP3 inflammasome.
Inflammasomes are intracellular multi-protein pattern recognition complexes that initiate and propagate
inflammation in response to cellular damage and stress associated with the reversible process of pyroptotic cell
death. The NLRP3 inflammasome has emerged as a key mediator of inflammation in PD, in part because it can
sense non-microbial inflammatory triggers commonly associated with chronic, age-related neurodegenerative
disorders. NLRP3 inflammasome triggers identified in models of PD include pesticides, heavy metals,
mitochondrial and oxidative stress, and proteinaceous insult. Environmental toxicant exposure is often systemic
and there is a growing appreciation of the role of the peripheral immune system in the response to toxicants and
the progression of PD. Characterizing PD-related mechanisms in peripheral immune cells may help to identify
signatures relevant to the progression of PD. Our studies in mice systemically exposed to rotenone identify a
Nlrp3-dependent peripheral immune response co-occurring with nigral neurodegeneration. Our study of PD
patients identified easily detectable plasma-borne indicators of NLRP3 inflammasome activity and elevated
plasma NLRP3 protein in PD patients, potentially related to military employment. These data provide a
compelling backdrop for our proposed characterization of peripheral NLRP3 activity in the context of PD. We
have developed innovative mouse models based on CRE-driven cell-type specific Nlrp3 gain-of-function. We will
limit Nlrp3 expression to peripheral myeloid cells and characterize the peripheral immune response,
neuroinflammation, and nigral neurodegeneration using an established rotenone exposure-based PD model. In
a second aim, we follow up on pilot studies to determine if the anti-inflammatory neuroprotective protein
Regulator of G-protein Signaling 10 (RGS10) functions to resolve NLRP3-inflammasome signaling. In a third
Aim, we team with the White River Junction VA Medical Center to evaluate subjects with prior military experience,
using established assays to characterize the relationship between circulating inflammasome-related proteins,
military occupation, and PD. Our ViCTER Consortium brings together experts in NLRP3 and toxicant-based
models of PD, RGS10 and PD-related immunology, and patient-based studies. The collaborators will employ
interdisciplinary strategies to characterize clinically relevant inflammatory mechanisms and inflammasome
activity in an at-risk patient population. Studies will provide a foundation for the development of diagnostic tools
and therapies to monitor, stratify, and treat PD.

Public health relevance
PROJECT NARRATIVE We have formed an interdisciplinary consortium to determine how the immune system responds to environmental toxicants that increase the risk of Parkinson’s disease. Pre-clinical and patient studies will improve our understanding of inflammation, inform the development of new anti-inflammatory drugs, and identify Parkinson’s patients in whom anti-inflammatory therapies would be most effective.